Operation of the COVID-19 Treatment Guidelines Website

The Coronavirus Disease 2019 (COVID-19) Treatment Guidelines have been developed to inform clinicians how to care for patients with COVID-19. Because clinical information about the optimal management of COVID-19 is evolving quickly, these Guidelines have been be updated frequently as published data and other authoritative information become available.

The Coronavirus Disease 2019 (COVID-19) Treatment Guidelines is published in an electronic format that can be updated in step with the rapid pace and growing volume of information regarding the treatment of COVID-19.

The COVID-19 Treatment Guidelines Panel is committed to updating this document to ensure that health care providers, patients, and policy experts have the most recent information regarding the optimal management of COVID-19.

The Coronavirus Disease 2019 (COVID-19) Treatment Guidelines was launched on April 21st, 2020, since then, there have been 52 updates to the guidelines, and received over 39 million page views, with over 60% of the viewers from the United States.